Decoding Positional Epigenetic Memory

PROJECT SUMMARY / ABSTRACT: DECODING POSITIONAL EPIGENETIC MEMORY
Hox gene expression is crucial for patterning the main body axis of all bilaterian species. In a classic epigenetic
memory fashion, positional identity is acquired early in development and is inherited through cell lineage via
Hox expression. Misexpression of even a single Hox gene can lead to homeotic transformations or diseases
like cancer, making stable and accurate Hox positional epigenetic memory essential for proper cell
differentiation and disease prevention. Building on a decade of seminal contributions to the field, our research
aims to decipher how stable Hox positional identity is generated.
In mammals, the Hox genes are organized into four chromosomal clusters, each containing a subset of 13
genes within approximately 100 kb. Polycomb Repressive Complexes (PRCs) decorate and suppress Hox
clusters in undifferentiated cells. Transient patterning signals such as retinoic acid partition Hox clusters into
active (PRC-removed) and repressed (PRC-high) domains at early differentiation stages, establishing precise
and stable boundaries that convey positional identity across cell generations.
We made three critical contributions to the accepted Hox positional epigenetic memory model. First, we
identified that patterning signals result in the binding of activating transcription factors to Hox cluster domains.
Second, we discovered that this binding results in PRC eviction from CTCF-established chromatin boundaries.
Lastly, we demonstrated that the Hox cluster is sufficient to establish positional identity. In other words, a 100
kb Hox cluster engages with the three elements required for positional memory: repression (PRC recruitment),
activation (signaling transcription factors), and boundary formation (CTCF). The ability of CTCF to engage in
boundary formation is an active area of research and the best-understood component. However, there is a
knowledge gap in the mechanisms that control activation and repression:
Challenge 1: Activation. The current working model cannot explain how Retinoic Acid signaling evicts PRC
while initiating a progressive colinear Hox gene transcription. Further, the model lacks definitive proof of the
physical distribution of the activating Retinoic Acid Receptor and CDX2 factors along Hox cluster domains. We
will challenge the Hox regulatory paradigm to the core by building novel Hox regulatory units with synthetic
DNA technology.
Challenge 2: Repressors. Although it is among the earliest examples of PRC repression, there is no
mechanistic understanding of how Hox clusters recruit PRC in mammalian cells. With our powerful synthetic
DNA approach, we will identify the mammalian Hox polycomb recruitment element (PRE).
By merging synthetic DNA, new genomic engineering tools, and stem cell differentiation systems, we aim to
understand positional memory through Hox chromatin boundary formation and build the smallest genetic unit
sufficient to establish and sustain positional epigenetic memory.

Public health relevance
NARRATIVE: DECODING POSITIONAL EPIGENETIC MEMORY Positional memory is critical for normal development and disease. Building on more than a decade of contributions to the field, our research aims to understand how the highly conserved Hox gene cluster translates signaling into epigenetic memory.